Advancing a novel therapy for preeclampsia

Advancing a novel therapy for preeclampsia
Abstract
Preeclampsia (PE) is a serious complication of pregnancy manifested by high blood pressure, proteinuria, and
edema, sometimes with encephalopathy, seizures, and hepatic failure. PE complicates from 5 to 10% of
pregnancies, and is a major cause of maternal and fetal morbidity and mortality worldwide. Nevertheless, no
effective therapy exists. There is no known specific treatment, although palliative measures such as
antihypertensive drugs, magnesium sulfate, and steroids, and early delivery improve outcomes. Elevation in the
circulating level of an endogenous "digoxin-like" factor (EDLF), an unknown substance that cross reacts with
anti-digoxin antibodies and inhibits the Na+/K+ ATPase (NKA) was first noted in the 1980s. An extensive literature
supports the hypothesis that increased levels of EDLF may be a causative factor in the pathogenesis of
hypertension. Recently, marinobufagenin (MBG), an endogenous cardiotonic steroid (CTS), has been identified
as the EDLF. Plasma MBG is elevated in pregnancy complicated by PE, suggesting it might play a role in the
pathophysiology of PE. Digibind (GlaxoSmithKline) is a commercially available anti-digoxin sheep polyclonal
antibody approved for the treatment of digoxin overdose. A clinical trial of Digibind in 51 patients with severe PE
showed significant improvement in renal function relative to placebo, with no adverse effects. Digibind cross-
reacts modestly with MBG, and also with other CTS. In contrast, an anti-MBG human monoclonal antibody
(humAb) is specific for MBG, with minimal cross-reactivity with other CTS. We have identified high-affinity anti-
MBG humAbs and evaluated their specificity for MBG over related cardiotonic steroids. We then evaluated the
most promising candidate humAbs for their ability to block MBG-mediated signaling. As a result of this work, we
identified an anti-MBG humAb with a nanomolar Kd, limited cross-reactivity with related CTS, and the ability to
block MBG effects on several pathways. During this Phase 1 project, we will conduct preclinical pharmacology
and toxicology studies: teratogenicity testing, plasma half-life, and dose-response studies in an animal model of
PE. Demonstration of efficacy without adverse effects will merit submission of a Phase 2 application. Phase 2
work will focus on obtaining additional preclinical data necessary for submission of an IND.

Public health relevance
Narrative Preeclampsia (PE) is a complication of pregnancy that affects 5-10% of pregnancies and can be life- threatening. PE patients are given supportive therapy, such as anti-hypertensives and steroids. No specific and effective therapy, other than delivery, exists. Recently, a digitalis-like factor, marinobufagenin (MBG) has been implicated as a causative factor in PE. We have identified a novel human monoclonal antibody with high specificity for MBG and have demonstrated its effectiveness in an animal model of PE. This innovative therapeutic humAb will be the first effective treatment of PE.